Precise Mechanism of Tunneling in Soybean Lipoxygenase 1

The research outlined here is designed to achieve three main tasks: 1) Kinetic isotope effects (13C, 2H, and 3H) will be used to elucidate the structure of the intermediate that immediately follows the rate- determining step in the soybean lipoxygenase 1 (LOX-1) catalyzed oxidation of linoleic acid. 2) The effect of the identity of the transferred hydron (2H or 1H) upon secondary kinetic isotope effects (zH and 3H) will be studied using a method which allows for the simultaneous determination of all relevant isotope effects. 3) Finally, the effect steric perturbations near the active site upon the degree of tunneling of both 1H and 2H will be explored using a combination of site-directed mutagenesis, kinetic isotope effects, and a quantitative theoretical model. Completion of the first goal above promises to benefit research in drug design in the near term as human lipoxygenases have been implicated in asthma, athereosclerosis, and cancer. Attainment of the second goal will aid in overall understanding of the importance of secondary motions within the substrate during the primary tunneling event. Finally, completion of the third objective will serve to explain how conformational perturbations and internal motions near the active site affect tunneling. The last two objectives will confer long-term benefits upon the research community and could aid in the understanding of other enzymes which utilize tunneling.